Anatomic Pathology Residency Program

Residents in the Anatomic Pathology Residency Program contribute to the clinical research program of the NCI and the NIH. Through their efforts as anatomic pathology residents in training, they help illuminate the pathological changes associated initial presentation and therapy of both neoplastic and non-neoplastic diseases and explore new techniques to improve diagnosis of these diseases. These residents are critical to the patient care activities of the NCI and the NIH, and contribute to the diagnosis and management of disease, especially COVID-19 this year. Residents have also contributed to publications dealing with characterization, diagnosis, and pathogenesis of a number of disease entities.